Alpha-Synuclein-Specific T cells in Parkinson's Disease Pathogenesis

PROJECT SUMMARY/ABSTRACT
Parkinson’s disease (PD) is the second most common neurodegenerative disease, characterized by pathological
hallmarks that include dopaminergic neuron death in the substantia nigra, a-synuclein (a-syn) aggregates in
Lewy bodies and neurites, neuroinflammation, and immune cell infiltration into the parenchyma. The
mechanisms which cause neurodegeneration in PD patients are not fully understood. Moreover, the ways in
which immune infiltration into the central nervous system (CNS) affects PD pathogenesis are unclear. Previously
published data by our group demonstrates that PD patients have T cells that recognize a-syn, suggesting a role
for autoreactive T cells in PD. This data also identified a risk allele, HLA DRB1*15:01, which binds to the a-syn32-
46 peptide with high affinity. Based on these findings, we tested how activation of the adaptive immune response
to a-syn in the periphery via immunization with a-syn32-46 in HLA DRB1*15:01 expressing mice may cause PD-
like pathology in the CNS. Interestingly, there was no CNS immune or neurodegenerative phenotype, but there
was a constipation phenotype and neuron loss in the intestines. This data suggests that activation of the immune
response against a-syn alone was insufficient to promote immune infiltration and subsequent PD pathology in
the healthy brain. Other mouse models for PD show that a-syn overexpression in the CNS induces infiltration of
T cells from the periphery, but it is unclear how infiltrating a-syn-specific T cells contribute to PD pathology. The
central hypothesis of this proposal is that activation of the immune response to a-syn in the periphery in
combination with a-syn accumulation in the brain promotes immune infiltration, neuroinflammation and
neurodegeneration. Aim 1 will assess neuroinflammation and neurodegeneration due to the combinatorial effects
of a-syn accumulation in the CNS and peripheral immune activation to the a-syn32-46 peptide using the
established immunization model combined with transgenic and viral a-syn overexpression mouse models. Aim
2 will dissect whether a-syn-specific T cells alone are sufficient to induce neuroinflammation and
neurodegeneration using adoptive T cell transfer of a-syn-specific T cells from a-syn-immunized mice into
unimmunized mice which overexpress a-syn in the CNS. The proposed studies will reveal whether autoreactive
a-syn-specific T cells infiltrate the CNS and promote PD pathogenesis. This knowledge may implicate
autoimmunity to a-syn as a major driver of PD, and promote the use of immunomodulatory therapies as a PD
treatment.

Public health relevance
PROJECT NARRATIVE a-Synuclein accumulates in the brains of Parkinson’s disease patients, and often coincides with immune cell infiltration from circulation into the brain. The proposed study will investigate whether autoreactive T cells targeting a-synuclein infiltrate the brain and contribute to neuroinflammation and neurodegeneration. This study has the potential to implicate autoimmunity as a driver of Parkinson’s disease pathogenesis, and point to potential immunomodulatory therapies for treatment of the disease.